ERYTHROPOIETIN USE IN HEMOLYTIC UREMIC SYNDROME

This prospective, randomized study will determine if erythropoietin begun soon after diagnosis of hemolytic uremic syndrome could lessen the number of red blood cell transfusions.